Systemic Delivery of Targeted Bi-Compartmental Nanoparticles for Glioblastoma Therapeutics

Abstract
Glioblastoma multiforme (GBM) is the prevalent primary malignant brain tumor accounting for 80% of all brain
cancer patients. It is typically associated with poor prognosis. The standard of care for GBM patients consists of
bulk surgical resection of the tumor mass in combination with focal radiotherapy and adjuvant chemotherapy,
using temozolomide (TMZ). Despite intense efforts, the prognosis of glioma patients remains dismal. Novel
approaches are greatly needed for this devastating form of brain cancer. Signal and Transducer of Activation 3
(STAT3) transcription factor has been proven to be a very attractive therapeutic target for malignant brain tumors,
as their growth is highly dependent of STAT3 signaling. Preliminary data from our team clearly suggest that
currently available small molecule STAT3 inhibitors are highly effective at eliciting regression of GBM tumors
growing in the periphery. In contrast, these same small molecule STAT3 inhibitors were ineffective in treating
GBM tumors located within the brain. We demonstrated that the lack of efficacy is due to limited BBB transport.
Similar difficulties are encountered for the delivery of other established chemotherapeutics, specifically paclitaxel
(PTX). Nanoparticle-based drug delivery systems offer potential solutions, but current delivery carriers have still
relatively low efficacy or require invasive intracranial delivery, to enable transport of therapeutics across the
blood-brain-barrier. In our preliminary studies, we were able to demonstrate that albumin-based drug delivery
carriers developed by our group significantly accumulate in intracranial tumors after systemic administration. In
this proposal, our interdisciplinary team will develop and evaluate a novel and scalable bi-compartmental human
serum albumin-based carrier system that allows controlled encapsulation of therapeutic ratios of STAT3 siRNA
and PTX within distinct compartments of the same albumin-based drug delivery carrier, while also incorporating
tumor-penetrating peptides, which have been previously shown to promote nanoparticle penetration into GBMs.
The experiments will test the hypothesis that the proposed bi-compartmental (bi-NP) STAT3i/PTX delivery
carriers in combination with standard of care, i.e., radiation therapy (IR) and TMZ, will significantly improve medial
survival of intracranial GBM bearing mice. We also hypothesize that the co-release of STAT3 siRNA and PTX,
when spatially and temporally orchestrated by an appropriately designed delivery carrier, will not exhibit
untoward adverse side effects in the host, neither within the brain, nor systemically. This work may result in a
new treatment modality for GBM, a tumor type, for which no effective treatments exist. New information on
accessing brain tumors with drugs will also ensue. Our ultimate goal is to translate this novel therapeutic modality
to patients with GBM by implementing Phase I clinical trials.

Public health relevance
Narrative Glioblastoma multiforme (GBM) is a malignant primary brain cancer which carries a dismal prognosis. STAT3 has been shown to be a very attractive therapeutic target for GBM; albeit, small molecule inhibitors of STAT3 signaling are ineffective, as they exhibit very poor blood brain barrier permeability. Our interdisciplinary team will develop and evaluate a novel and scalable bi-compartmental nanoparticle delivery system that allows controlled co-release of STAT3 siRNA and the chemotherapeutic agent, paclitaxel. This work may result in a new treatment modality for GBM, a tumor type, for which no effective treatments exist.